Role of microbiota, host genetics and mesenteric adipose in Crohn's disease fibrosis and post-op recurrence.

Ileal fibrosis in Crohn’s Disease (CD) represents a complication in over 30% of CD patients, and leads to surgery
in nearly 75% of this population. While therapies exist to manage CD-related inflammation, no approved
medication exists to prevent or manage fibrosis, with surgery left as the only option. Despite surgical removal of
fibrotic strictures, they often recur, requiring repeated surgeries. Strategies to predict who is more likely to
develop these complications, and identification of targets for therapeutic intervention is needed. Our long-term
goal is to develop a screening process for CD patients that incorporates a patient’s polygenic risk score, gut
microbiota profile, and metabolome to identify individuals at high risk for developing fibrotic disease (for newly
diagnosed patients) and propensity for disease recurrence (in individuals who have undergone surgery for
removal of strictures). In parallel, we hope to identify key microbiota strongly associated with fibrosis and define
their mechanism of action, so that microbially-directed therapy may become a viable therapeutic option for these
patients. Our objective in this proposal is to define the relationship between polygenic risk, the microbiome, and
the intestinal and peri-intestinal environment contributing to the fibrotic sub-phenotype in ileal CD. The central
hypothesis of this proposal is that CD patients who develop fibrotic disease and recurrent strictures represent a
sub-phenotype characterized by a hyper-reactivity of ileal immune cells, and fibroblasts in surrounding
mesenteric fat, to certain microbiota. We hypothesize that immune reactivity to these microbiota in both the ileum
and mesenteric fat may be determined by an individual’s polygenic risk score. Our rationale is that the
identification of mechanisms to predict development of fibrosis will offer new therapeutic opportunities. Our
specific aims will test the following hypotheses: (Aim 1) genetic susceptibility to ileal fibrosis is mediated by an
excessive immune response to creeping fat (CrF) microorganisms; (Aim 2) ileal fibroblasts express collagen
matrix genes in the context of inflammation, is microbially-driven, and is related to propensity for recurrent
strictures; and (Aim 3) microorganisms associated with CrF will increase penetrance, severity, and/or shorten
time to disease in a model of spontaneous fibrosis. This contribution is significant because it will add new aspects
to our understanding of CD fibrosis by studying the microbiome, mesenteric fat, and polygenic risk scores to help
define this complicated phenotype. These insights have the potential to offer new targets and points of
intervention before complications occur. This option currently does not exist. Furthermore, this study will provide
the most comprehensive characterization to-date of creeping fat and help answer the mystery of why this
phenomenon occurs. This contribution is innovative because no studies to-date have investigated ileal CD
fibrosis taking into account the contribution of creeping fat to the fibrotic milieu. Insight into the peri-intestinal
environment, combined with microbial targets, and an individual’s genotype represents a combination of
analyses that is both new, clinically relevant, and ultimately, translatable into future patient care.

Public health relevance
The proposed research is relevant to public health because Crohn’s Disease, increasing in prevalence, consists of poorly defined sub-phenotypes that require better classification in order to optimize therapeutic intervention. Propensity for ileal fibrosis and recurrent disease, one such sub-phenotype, is a complication present in 30% of CD patients, and will ultimately require surgery in as much as 75% of these individuals. No approved therapeutic exists to prevent or manage fibrosis, therefore findings from this study, which will characterize the fibrotic sub- phenotype based on host genetics, microbiome, and peri-intestinal mileiu will open a new avenue for developing therapeutic interventions.